Instant and reversible wet tissue adhesive tape

ABSTRACT
Minimally invasive surgery (MIS) is favored for its benefits, such as reduced pain, shorter recovery times, and
minimized scarring, with 7.5 million laparoscopies performed worldwide in 2015. Procedures like lung cancer
surgery, tubal ligation, cholecystectomy, gastric bypass, myomectomy, and prostatectomy are predominantly
conducted using MIS, a trend expected to grow by up to 15% in the next 5–10 years. However, adapting surgical
tools for the confined environments of MIS remains challenging. Traditional retractors and stabilizers often cause
tissue damage and can detach during procedures, and their bulkiness limits their effectiveness. Effective
hemostasis in gastrointestinal (GI) surgeries using endoscopic methods is a critical unmet need, as current
methods like mechanical clips, thermal coagulation, and injection therapies face challenges with precision,
potential tissue damage, and risk of rebleeding.
Tissue adhesives that can adhere to wet tissues in confined environments could provide effective wound
closure and tissue retraction. Currently available tissue adhesives, such as fibrin sealants (e.g., Tisseel™),
cyanoacrylate-based glues (e.g., Histoacryl™, Dermabond™, Omnex™), and protein/peptide-based glues (e.g.,
BioGlue™, TissuGlu™), have limitations such as limited adhesion strength, inability to reposition, and toxicity,
making them less suitable for MIS. An ideal tissue adhesive for MIS should be easy to apply, rapidly adhere to
wet tissue, repositionable, avoid reactive chemistry or ionizing radiation, withstand multiple
extension/compression cycles, and be biocompatible and resorbable.
This proposal aims to develop a novel PSB system for MIS. Pressure-sensitive adhesives (PSAs) form
instant, reversible attachments through viscoelastic properties and have potential applications in MIS by enabling
easy repositioning and removal of surgical equipment, minimizing tissue damage, and enhancing surgical
adaptability. Despite their potential, available medical PSAs do not attach to wet internal organs because water
on the wet tissues blocks the direct contact of the viscoelastic PSAs to the tissue. Our preliminary studies on a
PSB based on poly(glycerol sebacate) (PGS) combined with poly(ethylene glycol) (PEG) show that it can adhere
instantly to wet tissues like the heart and lungs, even in the presence of blood or body fluid. The PSB can be
integrated with medical devices without specific surface chemistry limitations. Reversible adhesion provides
atraumatic detachment and reattachment, reducing tissue damage and assisting surgeons with adaptable
positioning during procedures.
Aim 1. Fabricate PSB with tunable viscoelastic properties and adhesive properties to different types of tissues.
Aim 2. Explore the PBS's performance for minimally invasive applications.
Aim 3. Evaluate the feasibility of PSB for translational MIS scenarios – hemostatic adhesive and tissue
stabilization during endoscopic procedures.

Public health relevance
PROJECT NARRATIVE Pressure-sensitive adhesives (PSAs) have been a workhorse in diverse applications from the repair of objects to heavy-duty industrial use due to their unique capability to form near-instant and robust yet repeatable adhesion to a wide range of engineering solids via physical bonding. While these characteristics of PSAs are highly favorable in various biomedical applications, commercial PSAs lack adhesion to wet tissue surfaces. This proposal introduces a pressure-sensitive bioadhesive (PSB) that synergistically combines the advantages of viscoelastic PSAs and bioadhesives and evaluates its use for minimally invasive surgeries.